SCH: AI-empowered wearable multimodal sensors (AI-MEDALLION) for noninvasive monitoring

Over the last decade, significant progress has been made in wearable sensors that detect biomarkers in a
continuous and non-invasive manner from biofluids such as sweat. Parkinson's disease (PD) is the
second-most common neurodegenerative disorder in the United States, and early diagnosis and
management of the disease course of PD remains an urgent task. Among all biomarker types, the sweat
metabolites, peptides, and anions can reflect both the phenotypic states of cells or organs and their
dynamic responses to external stimuli, such as drug treatment. However, significant technical challenges
exist in developing sweat metabolic biomarkers and wearable sweat sensors in PD monitoring: 1) lack of
known biomarkers and accurate whole metabolomic and peptide profiles in PD patients' sweat; 2) the
selected biomarkers need to be optimized for PD system and sensor technology; 3) current wearable
sweat sensors fall short in sensitivity. This project aims to fill these gaps by proposing a novel framework
for predicting and optimizing the PD metabolic biomarkers using large-scale multi-omics data, to innovate
non-invasive wearable sweat sensor with high sensitivity and specificity. Specifically, the biomarker
panels and sweat sensor will be developed by bridging state-of-the-art AI and nanotechnologies to assist
the diagnosis and monitoring of PD, and will be validated clinically. The proposed research will provide an
integrative infrastructure for developing novel PD biomarkers and non-invasive personal wearable
devices. We will develop computational methods to solve a set of unaddressed questions in biomarker
discovery, namely identification of PD-specific functional variations, prediction of metabolites and peptides
in body fluids, and optimization of biomarker selection for personal wearable sensor (Aim 1). We will gain
fundamental knowledge and technical capabilities in designing, processing, and optimizing of 2D
materials-based wearable sensors for versatile applications. A physics-based, data-driven protocol will be
developed to reveal the fundamental process-structure-property-performance relation for wearable
sensors (Aim 2). We will develop new biomarker sets and wearable sweat sensors and test the
performance in assisting diagnosis and monitoring of PD, which could be extended to other
biological/disease systems (Aim 3). This proposed study will fill the gaps of disease-specific biomarker
prediction and 2D material optimization in developing a clinically applicable non-invasive wearable device.

Public health relevance
RELEVANCE (See instructions): The proposed project utilizes multiple data sources and collects different data modalities to develop biomarkers and personal wearable sensors to monitor the treatment effectiveness and progression of Parkinson's diseases, which directly align with the mission of NLM. The proposed computational methods can be generally applied by biological researchers to study disease specific metabolisms and variations and can be extended to study other species or biological systems. The proposed wearable sensor